Structure Determination of Heterologous and Native AMPA Receptors and their Complexes with Auxiliary Subunits

PROJECT SUMMARY/ABSTRACT
The goal of this project is to determine the mechanisms of activation of ionotropic glutamate receptors (iGluRs)
in complex with various auxiliary subunits, as well as elucidate compositional heterogeneity of iGluR subunit
assembly between humans and other mammalian species. iGluRs are tetrameric ligand-gated ion channels
responsible for the majority of excitatory neurotransmission in the central nervous system. Within neurons,
iGluRs play key roles in brain function, including memory and learning, and their dysregulation leads to
neurological and neurodevelopmental impairments, such as epilepsy, ischemia, and intellectual disability. The
fastest iGluR subtype, α-amino-3-hydroxy-5-methyl-4-isoxazolepropionic acid receptors (AMPARs), assemble in
the postsynaptic densities as homomeric or heteromeric complexes consisting of four primary subunits, GluA1
to GluA4. In addition to the core subunits, AMPARs co-assemble with many transmembrane cofactor proteins,
or auxiliary subunits, that modulate the kinetics, trafficking, localization, permeation, and pharmacology of the
receptor. Current structures of AMPARs in complex with several auxiliary proteins, specifically transmembrane
AMPAR regulatory proteins (TARPs), germline-specific gene-1-like protein (GSG1L), and cornichons (CNIH2/3)
lack details about the regulation of activation. Moreover, AMPAR structures have only been resolved from
recombinant overexpression or extracted from rodent brains, while the composition of AMPAR synaptic
complexes in human brains remains understudied. The proposed functional and structural studies of AMPAR
synaptic complexes with auxiliary subunits in the open conducting state, a key conformational state for
therapeutic intervention, and the delineation of human AMPAR assemblies will provide necessary, novel insights
toward future drug design for the targeted treatment of psychiatric and neurological disorders linked to AMPAR
dysfunction. AMPAR structure and function will be studied following two Specific Aims. Aim 1: Determine
activation mechanisms of AMPARs bound to TARPs, GSG1L, and CNIHs. Aim 2: Structurally characterize
subunit composition of human AMPARs. To achieve these aims, a combination of fluorescence-detection size-
exclusion chromatography (FSEC) screening, cryo-electron microscopy (cryo-EM), whole-cell patch-clamp
electrophysiology, and single-channel recordings will be used. The results of these studies will expand our
understanding of AMPAR gating modulation by auxiliary subunits, provide insight into the brain-region-specific
AMPAR subunit organization in humans, and foster the development of specialized therapies for clinical
treatment of AMPAR-related neurological disorders.

Public health relevance
PROJECT NARRATIVE Fast excitatory neurotransmission within the central nervous system is primarily facilitated by postsynaptic ionotropic glutamate receptors (iGluRs), most prominently by their fastest subtype, the α-amino-3-hydroxy-5- methyl-4-isoxazolepropionic acid receptors (AMPARs). Dysregulation of proper AMPAR function leads to neurodegenerative, neuropsychiatric, and neurodevelopmental disorders, including autism spectrum disorder, epilepsy, Parkinson’s Disease, and schizophrenia. The proposed research project will determine high-resolution three-dimensional structures of recombinant and human-brain extracted AMPAR complexes, resolving mechanisms of their functional modulation and guiding future efforts in developing new therapeutic strategies for treatment of iGluR-related neurological diseases.